Non-coding RNA in the olfactory system of Drosophila

Project summary
Odor detection and identification are critical to animal survival. Major questions remain about the
molecular mechanisms by which olfactory systems are modulated by environmental conditions and
the internal state of the animal. Non-coding RNA (ncRNA) remains virtually unexplored in olfaction.
Many structural and functional features of ncRNA could be exploited in olfactory coding and
modulation, and a rapidly expanding body of evidence shows that ncRNA plays a profound role in
other neural systems. Drosophila is a powerful model organism in which to investigate the potential
role of ncRNA in the molecular basis of odor perception. This proposal concerns ncRNA in the
Drosophila antenna, with a focus on one particularly intriguing ncRNA.
In preliminary work, I characterized the antennal ncRNA landscape of D. melanogaster and
identified 10 abundant ncRNAs that are enriched in the fly antenna, including 4 that are enriched in
food- and/or pheromone-sensing sensilla. I found that one of these ncRNAs is upregulated when
the animals are starved and I named it ANRUS, Antennal ncRNA Upregulated by Starvation. The
proposed project is designed to characterize these antennal ncRNAs, with a focus on ANRUS.
The first aim is to determine the expression pattern of ANRUS. I will perform single molecule
fluorescence in situ hybridization to determine in which cells and cellular compartments this ncRNA
is localized, which may give clues to its function. If detected in neurons, I will identify the neuronal
class in which the ncRNA is expressed. The results may suggest that an ncRNA acts in the
response to certain odors. Dynamics of ANRUS localization will be assessed across certain
conditions (e.g. starvation, pre-exposure to odorant, isolation and age). Changes in subcellular
localization may indicate a role in adaptation to the corresponding environmental or internal state.
The second aim is to characterize flies lacking ANRUS. I have generated mutant flies lacking
ANRUS, and preliminary electrophysiological measurements revealed that in flies lacking ANRUS,
certain neurons fail to increase their olfactory sensitivity under starvation. I will further examine the
mutant flies in electrophysiological and behavioral assays to test the hypothesis that this ncRNA
plays an essential role in olfactory modulation and coding in starved flies.
The overarching goal of this project is to broaden our understanding of the molecular basis of
olfaction. Ultimately, this project could reveal new principles of sensory coding and new roles of
ncRNAs.

Public health relevance
Project Narrative Insects can be detrimental to human populations due to the transmission of a variety of diseases and agricultural destruction. Chemosensory systems are critical for the effectiveness of these insects; olfaction is particularly important for navigating through the environment and finding human hosts and food. This project is designed to understand the molecular mechanisms by which these systems operate and could lead to new methods of controlling these insects and their impact on humans.